Center for Quantitative Biology: A focus on "omics", from organisms to single cells

Center for Quantitative Biology: A focus on "omics", from organisms to single cells
PROJECT SUMMARY
High-throughput single-cell, spatial, and immune-cell -omic profiling technologies provide a wealth of data to
interrogate basic biological processes, changes in cellular processes, and the molecular basis of disease. When
combined with genomic data science, these fields are opening new frontiers in biology. Phase 1 established the
Center for Quantitative Biology (CQB) with the goal to support and enhance NIH-funded quantitative biological
research at Dartmouth and to facilitate integration of single-cell -omic technologies with cutting-edge
computational methods. The success of the CQB in Phase 1 is highlighted by the graduation of four Research
Project Leaders (RPLs), the onboarding of four new RPLs, and the hiring of seven new tenure-track faculty in
CQB focus areas. The IDeA program investment in CQB RPLs and research cores returned >$60 million in total
external funding, leveraging NIH funds 5:1. Phase 2 will build on the successes of Phase 1 by mentoring the
next generation of CQB COBRE RPLs, continuing growth of research cores, and enabling scientists to engage
in cutting-edge scientific inquiry. The CQB will continue to draw upon faculty from Dartmouth’s Geisel School of
Medicine, the Thayer School of Engineering, Arts & Sciences, and Dartmouth Health. Through its emphasis on
next-generation data, the CQB will synergize genomic data science with ongoing experimental genomic
initiatives across campus, a goal accomplished via four specific areas: 1) Enhance the research competitiveness
of junior faculty in genomic data science and experimental genomics by providing a research environment that
supports and enhances their projects. 2) Expand the breadth and impact of research from NIH-funded
quantitative biologists at Dartmouth by: (a) continuing to recruit talented quantitative biology faculty; (b)
mentoring junior quantitative biologists; and (c) providing systems for translating single-cell dynamics to
applications in human disease. 3) Develop, maintain, and leverage key shared resources to support faculty in
the CQB, at Dartmouth, and in the IDeA community by growing the Single-Cell Genomics and Genomic Data
Science Cores. 4) Create synergistic interactions between the dry-lab computational scientist and traditional
experimental scientist to promote cross-talk, collaboration, and integrative analyses between the disciplines.
Dartmouth continues to make a substantial institutional commitment to the success and long-term sustainability
of the CQB, including the commitment to hiring five new tenure-track faculty. Institutional program enrichment
funds will support research infrastructure, scientific exchange, and a pilot project program to foster a vibrant
intellectual community, recruit new project leaders, and enhance the impact and funding competitiveness of all
CQB members. With experienced leadership, efficient administrative structures, and a compelling vision, CQB
has demonstrated a paradigm that interweaves computational and experimental early-stage translational
research, allowing the CQB to grow its portfolio of extramurally-funded investigators and thrive as a nationally-
recognized Center of Biomedical Research Excellence.

Public health relevance
Center for Quantitative Biology: A focus on "omics", from organisms to single cells PROJECT NARRATIVE Phase 2 established a Center for Quantitative Biology (CQB) that nucleated and grew the fusion of wet-bench “- omics” research with bioinformatics at Dartmouth. The center nurtured and mentored new projects that sought to understand changes in cells and tissue biopsies, including the detail of single-cell dynamics, using high- throughput methods and integration of diverse ‘-omic’ data that are now being applied widely to multiple systems, diseases, cell types, and organisms to improve our understanding of healthy tissues and disease processes. Phase 2 will continue to build and grow the COBRE Center for Quantitative Biology that provides unique resources to investigators at Dartmouth and our IDeA partners, enhancing research productivity and funding competitiveness across the region.